Mechanisms of phthalate-induced ovarian follicle toxicity

PROJECT SUMMARY The purpose of this application is to support the transition of Dr. Zelieann R. Craig, a postdoctoral fellow in the Department of Comparative Biosciences at the University of Illinois, into an independent research career. Dr. Craig will be mentored by Dr. Jodi A. Flaws. The main goal of this application is to provide Dr. Craig will all the technical and professional skills necessary for her to become a successful independent investigator and leader in her field. In the research training component of this proposal, Dr. Craig will investigate the mechanisms by which phthalates, a group of endocrine disrupting chemicals, cause ovarian follicle toxicity. Further, she will investigate the mechanism by which 17β-estradiol, the major ovarian estrogen, partially prevents the effects of phthalates on ovarian follicles. Specific aim 1 will determine whether phthalates suppress growth of mouse ovarian follicles by decreasing proliferation of follicular cells. Specific aim 2 will determine whether phthalates suppress growth of mouse ovarian follicles by inducing apoptosis in follicular cells. Finally, specific aim 3 will determine the mechanism by which 17β-estradiol prevents phthalate-induced suppression of mouse ovarian follicle growth and increased follicular death. Findings from these studies will provide basic information on the reproductive toxicity of phthalates as well as mechanisms of action for these chemicals. Thus, findings from these studies may contribute to research aimed at the discovery of potential targets for the treatment of infertility caused by environmental chemical exposure.

Public health relevance
PROJECT NARRATIVE Relevance This project will help Dr. Zelieann Craig successfully mature into an independent researcher. Through the experiments proposed here, Dr. Craig will contribute to expanding our knowledge on the mechanisms by which phthalates affect ovarian function and cause infertility in animal models. Finally, results from this project will also contribute to research aimed at the identification of new treatments to reverse female infertility caused by environmental chemical exposure. __SpecificAimsTextDelimiter__ SPECIFIC AIMS About 10% of American women are infertile [1]. A woman's risk for infertility can be exacerbated by aging, stress, cigarette and alcohol abuse, and exposure to environmental contaminants such as endocrine disrupting chemicals (EDCs) [2]. The ovary is the primary reproductive organ in women and the ovarian follicle is its functional unit. Ovarian follicles, specifically those referred to as antral, contain the oocyte (egg) required for fertility and produce the ovarian sex steroid hormones required for maintenance of reproductive organs (e.g. ovary and uterus), and non-reproductive organs (e.g. bone and heart). Altered antral follicle function can lead to adverse outcomes such as anovulation, infertility, estrogen deficiency and premature ovarian failure. Also, disrupted antral follicle function may increase the risk for disorders associated with estrogen deficiency such as osteoporosis, cardiovascular disease and depression [3-5]. Phthalates are EDCs that represent an important public health concern because they are present in household items, infant products, beauty products, medical devices and in the enteric coating of certain oral medications [6-9]. Data on human phthalate exposure and female fertility outcomes have been limited, but phthalates have been detected in >75% of tested human spot urine samples [6], an indication of constant daily exposure. Interestingly, higher urinary phthalate levels have been reported in women of reproductive age (versus other sex/age groups; [6]). Further, increased phthalate exposure has been associated with decreased pregnancies and increased miscarriage rates in women [10]. Animal studies have demonstrated that di-2-ethylhexyl phthalate (DEHP), the most widely used phthalate, leads to prolonged estrous cycles, decreased levels of 17β- estradiol (E2; major ovarian estrogen) and altered ovulation rates in rats [11], and to overall decreased fertility in mice [12]. DEHP has also been shown to cause a reduction in the granulosa cell area of preovulatory follicles of rats without affecting antrum and oocyte size [11]. Previous studies by our group have shown that DEHP, mono-2-ethylhexyl phthalate (MEHP) and dibutyl phthalate (DBP) suppress antral follicle growth in vitro, and increase the number of apoptotic bodies present in antral follicles ([13] and preliminary data). Furthermore, it has been shown that co-treating antral follicles with DEHP or MEHP with E2 partially protects follicle growth. However, the mechanism by which these phthalates suppress antral follicle growth and E2 prevents their effects remains to be determined. Therefore, the main objective of this proposal is to determine if the mechanism by which these phthalates suppress antral follicle growth includes alterations in cell proliferation and apoptosis, and to determine which signaling pathways are required for the beneficial effects of E2. These studies will expand our understanding of the effects of phthalates on ovarian function as well as point out signaling pathways and cellular processes that can be targeted in the development of therapeutics for preventing and/or reversing EDC-induced infertility. The overall hypothesis is that phthalates suppress antral follicle growth by interfering with signals required for the proliferation of follicular cells thus causing cell cycle arrest and increased apoptosis. The rationale for the experiments proposed here is based on previous studies showing that exposure to DEHP and DBP cause decreased fertility in rodent models, decreased mouse antral follicle growth in vitro, increased atresia of mouse antral follicles in vitro, and that increased phthalate exposure is associated with adverse reproductive outcomes in women. To test the overall hypothesis, we propose the following three specific aims: Specific Aim 1. Determine whether phthalates suppress growth of mouse antral follicles by decreasing proliferation of follicular cells. The working hypothesis is that phthalates alter the expression of cell cycle genes leading to cell cycle arrest which results in decreased proliferation of the follicular cells and decreased growth of the follicular structure. Specific Aim 2. Determine whether phthalates suppress growth of mouse antral follicles by inducing apoptosis in follicular cells. The working hypothesis is that phthalates alter the balance between important regulators of apoptosis thus favoring apoptosis and causing death of the entire follicle. Specific Aim 3. Determine the mechanism by which 17β-estradiol (E2) prevents phthalate-induced suppression of antral follicle growth and atresia. The working hypothesis is that E2 acts via estrogen receptors to prevent inhibition of growth and increased atresia in phthalate-treated follicles.